Data Science Core

Project Summary/Abstract
Advancing capacity in data science holds great promise for the analysis and interpretation of vast amounts of
biomedical data. It is key for modeling complexities that facilitate a deeper understanding of biological processes
and promotes multidisciplinary integration, enabling more effective collaborative and innovative research
approaches. The application of data science is hindered by insufficient computational training, the accelerated
pace of data generation, and the need for expertise and infrastructure often lacking at smaller institutions. This
lack of experience and training capacity is exacerbated at Primarily Undergraduate Institutions (PUIs) without
the critical mass to establish a Data Science Core (DSC).
The overall goal of the NH-INBRE Data Science Core (DSC) is to support the data science needs of
ongoing and new research projects by integrating data science training across our partner institutions. The
proposed support extends through all phases of research projects and includes access to state-of-the-art
computational infrastructure supported by NH-INBRE. To provide the most comprehensive support as a
sustainable resource, we have combined support from a variety of sources to create and sustain a single
statewide DSC with broad capacities.
To accomplish our goals, we have two specific aims:
Aim 1: Enhance the biomedical research capacity of New Hampshire at the eight primarily undergraduate
institutions and the two lead institutions of the NH-INBRE by: 1) Supporting the data science needs of NH-
INBRE research projects and enhancing sustainability of computational expertise across the network by
providing support in diverse data science applications. 2). Providing sustainable, accessible, cost-effective, and
well-managed computational infrastructure for data analysis, storage, and dissemination.
Aim2: Create a sustainable, scalable, and impactful mechanism for training in data science by:
Establishing and disseminating new training modules in aspects of data science and collaborating with Northeast
INBRE Core directors to lead a team effort toward data science curriculum and research support.
Achieving these goals will meet the research needs of INBRE-supported investigators and network
partners for data science services and support the development of key skills and rigorous practices in alignment
with the NIH strategic plan for data science.